Hack2Health: Developing A Teen-Led Digital Intervention for Reducing Negative Social Comparison on Social Media

Project Summary/Abstract
Most youth use social media (SM) every day, and many concerns have been raised about how SM use may be
driving the alarming increases in anxiety and depression among adolescents. However, current research
suggests that not all youth are equally impacted by SM, and some SM users are at higher risk than others for
negative health outcomes. Emerging research suggests that one likely individual difference that may account
for the disparate outcomes is youths’ tendency towards engaging in negative social comparisons (i.e.,
evaluating their own lives or selves negatively in comparison to others) while using SM. Negative social
comparison is thus a promising target for intervention, particularly interventions delivered digitally to youths’
smartphones, where they are most likely to be using SM. As youth are the experts on their own digital
technology and SM use, it is critical to center youths’ voices in all stages of developing such an intervention.
Thus, the present study empowers older adolescents (ages 15-18) to design, pitch, and create (with
collaboration from technical experts) a brief digital intervention that targets negative social comparison on SM
to reduce anxiety and depression in teens. This study focuses on older adolescents specifically as they are
becoming more independent users of SM and at high risk for the development of anxiety and depression. In
Phase 1, 25 teens will receive expert training and mentorship to design and pitch their intervention in a full-day
hackathon. In Phase 2, 10 teens will develop the most promising intervention pitched in Phase 1 and it will be
programmed in collaboration with professional developers. In Phase 3, the final intervention will be tested in a
small randomized controlled trial with 40 new teens high in anxiety and/or depression symptoms who report a
tendency toward negative social comparison on SM. Objective data on SM content engagement and ecological
momentary assessment (EMA) data on clinical symptoms and other socio-emotional variables (e.g., self-
esteem, social avoidance) will be collected for ~five weeks from pre-intervention to post-intervention. Phase 3
will allow for preliminary tests of the intervention’s feasibility, acceptability, and target engagement (i.e., impact
on the target mechanism: negative social comparison), as well as candidate mechanisms that might help
explain the intervention’s effects on reducing negative social comparison (i.e., changes in interpretation biases
or youths’ SM engagement patterns) and clinical outcomes (i.e., changes in rumination, social behaviors,
and/or body image concerns), which will set the stage for a future, full-scale clinical trial.

Public health relevance
Narrative Most youth frequently use social media, but not all youth will be harmed by their social media use. Youth with a tendency to engage in negative social comparison (i.e., judging their self-worth more negatively in comparison to others) while using social media may be at higher risk for anxiety and depression; thus, interventions that reduce youths’ tendency towards negative social comparison on social media may have meaningful impacts on their mental health. Using a youth-centered approach through a multi-stage hackathon and youth advisory co- design process, this study empowers older teens to design their own brief digital intervention that targets negative social comparison and pilot tests the intervention to understand its feasibility, acceptability, and effects on social comparison and youths’ mental health.